Administrative Core

Administrative Core
Project Summary
The Administrative Core will provide overall management, coordination and oversight to ensure the
achievement of the Phase III CoBRE program's two major objectives: 1) facilitate the transition of research
cores to sustainable state-of-the-art facilities; 2) sustain the research environment by supporting pilot research
projects and career guidance and enhancement. This will be accomplished through the following specific aims:
1) provide administrative support and coordinate Center activities, 2) oversee the functioning and development
of research cores to ensure their sustainability, 3) oversee the Pilot Project Grant Program, 4) facilitate
research and career development opportunities for Center investigators, 5) foster scientific interactions and
collaborations among Center investigators and other IDeA programs, 6) recruit additional Center investigators
and increase Center visibility, 7) ensure compliance with local and federal research regulations on human
subjects, vertebrate animals and biosafety, and 8) coordinate CoBRE program evaluation.